Translational studies to advance Filociclovir to IND submission for the treatment of adenoviral conjunctivitis and acute keratoconjunctivitis

Project Summary/Abstract
The long-term goal of this project, to develop filociclovir (FCV) for the safe and effective
treatment of human adenovirus (HAdV) ocular infections, especially HAdV-related epidemic
keratoconjunctivitis (EKC), a stated National Eye Institute (NEI) research priority. There are
currently no treatments for patients suffering from adenoviral conjunctivitis, which is responsible
for up 8.5 million lost work days and $1.9 billion in lost wages every year in the U.S., or EKC, the
most severe form of ocular adenoviral infection, which often causes long-term visual sequelae,
such as chronic keratitis and vision loss. As FCV has previously completed Phase 1 clinical
studies for a systemic indication of cytomegalovirus (CMV) infection in solid organ transplant
recipients, the objective of this R33 proposal is to generate the remaining ocular-specific
preclinical (PC) data needed to support an investigational new drug (IND) submission to treat
ocular HAdV infections. In this proposal, final formulation work and IND-enabling GLP-toxicology
studies will be completed, along with confirmatory efficacy parameters, suitable for IND
submission. We will continue to communicate with the FDA to ensure that the correct study
designs are in place. The specific aims of this proposal, along with the research design and
milestones, are as follows:
AIM 1. Finalize eye drop formulation with suitable preservatives, confirm efficacy in the
rabbit HAdV infection model and select a device (eye dropper) (year 1). Milestones:
Formulation suitable for two species IND-enabling GLP toxicology and advancement into human
studies, formulation passes Antimicrobial Effectiveness Testing (AET), efficacy in rabbit eye
model and final device selected.
AIM 2. Perform IND-enabling GLP ocular toxicology in rabbits and dose range-finding
ocular tolerance and GLP ocular toxicology in rats (years 2-3). Milestones: Completion of
acute tolerance studies in rats, GLP 14-day ocular toxicology in rabbits and rats to support an
IND filing, NOAEL ≥ 0.5% dosed QID.
AIM 3. Complete regulatory requirements, including communications with the FDA, IND
application and clinical trial design (years 2-3). Milestones: Pre-IND meeting with the FDA
(follow-up to the Type C meeting held January 3, 2024), IND application and clinical trial design
completed.

Public health relevance
Translational studies to advance Filociclovir to IND submission for the treatment of adenoviral conjunctivitis and acute keratoconjunctivitis Project Narrative The overall goal of this project is to develop filociclovir (FCV) as a safe and effective treatment for the most common cause of ocular infections, human adenovirus. There are currently no treatments for patients suffering from: (i) adenoviral conjunctivitis, which is responsible for up to 8.5 million lost workdays every year in the U.S., or (ii) epidemic keratoconjunctivitis (EKC), the most severe form of ocular adenoviral infection, which often causes long-term visual sequelae, such as chronic keratitis and vision loss. This project will complete FCV’s ocular preclinical development, including interactions with the FDA and position it for human clinical trials as a first-in-class anti-adenoviral inhibitor.